Targeting KLF10 to prevent cancer-associated muscle loss

ABSTRACT
Skeletal muscle wasting affects up to 80% of patients with advanced cancer and directly impacts surgical
prognosis, chemotherapeutic response, morbidity, mortality, and quality of life. Treatment options for patients
experiencing cancer-associated muscle wasting/cachexia are limited. Our long-term goal is to develop and
leverage a detailed molecular understanding of skeletal muscle wasting to identify novel treatment paradigms
that limit lean mass loss in cancer patients. TGF-β-associated signaling is a well-established driver of cancer
cachexia, with many superfamily members (such as Activins A/B, Growth-Differentiation Factors (GDFs), and
Myostatin) implicated in multiple cancer cachexia models as well as in humans. Despite clear links to the etiology
of cancer cachexia, efforts to target the TGF-β pathway have not achieved great clinical success. This disconnect
presents an opportunity to better define TGF-β-associated signaling in cancer cachexia, and in the process,
identify better targets for therapeutic intervention. We present preliminary data implicating the TGF-β target gene
KLF10 as a key mediator of cancer-associated muscle wasting. We show that KLF10 suppression/inactivation
suppresses cancer-associated muscle wasting and further demonstrate that KLF10 is sufficient to drive the
atrophy program. We directly link KLF10 to TGF-β-associated atrophy and show that KLF10 can bind to and
regulate the atrophy-associated gene (atrogene) MuRF1. Considering these and other data, the central
hypothesis of this proposal is that a TGF-β::KLF10::MuRF1/atrogene signaling axis promotes muscle wasting in
tumor-bearing mice. We will test this hypothesis by completing the following objectives: 1) we will delineate TGF-
β-associated inputs that drive muscle KLF10 expression and cancer-associated muscle wasting, 2) we will define
KLF10 targets responsible for wasting-associated phenotypes, and 3) we will develop and test strategies to
inhibit KLF10 in pre-clinical cancer cachexia models. Successful completion of these aims will address a critical
mechanistic knowledge gap regarding a well-known atrophy-associated signaling pathway and will be a
significant step towards developing novel therapies to combat cancer-associated muscle wasting.

Public health relevance
PUBLIC HEALTH RELEVANCE The proposed studies will use cell/molecular biology, biochemistry, and mouse modeling to characterize a novel driver (KLF10) of cancer-associated muscle wasting. The long-term goal of our group is to develop and characterize interventions designed to combat cancer-associated muscle loss, thus improving patient outcomes and quality of life.